Skeletal, Craniofacial and Oral Biology Training Grant

Project Summary:
This is a proposal for the continuation of the Institutional Training Program in Skeletal, Craniofacial and Oral
Biology at the UConn Health, School of Dental Medicine as a T90/R90 program. It is intended to help meet the
substantial need for independent scientists trained in research related to improving oral, dental and craniofacial
health in the United States. The program has and will continue to train scholars (DMD and non-DMD) who are
competent as clinicians and independent scientists, who are able to initiate and maintain funded research
programs, who understand multidisciplinary research and who are prepared for the evolution of their research
into new directions. Areas of research training include Tissue Engineering and Regenerative Medicine, Cell
and Cancer Biology, Computational Biology, Genomics and Bioinformatics, Craniofacial and Skeletal Biology,
Gene Regulation, Immunology, Microbiome/Microbiology, Oral Biology, Stem Cell Biology, and clinical and
translational research. The major tracks of the training program are the (i) DMD/PhD (7-8 yrs of training with 3-
5 yrs of support from this training grant; 4 present trainees, 1-4 (depending on success of F30s) additional
trainees requested over five yrs), (ii) PhD (4-5 yrs of training with 3 yrs of support; 3 present trainees, 6
additional trainees requested), (iii) postdoctoral research (3 yrs training and support; 3 present trainees, 5
additional trainees requested) and (iv) non-citizen PhD trainees (with DDS degrees) (3-5 yrs of training with 3
yrs of support; 1 present trainees 2 additional trainees requested). We will be training individuals with a broad
range of backgrounds, from those with BS/BA degrees to those who have completed PhD and/or dental
residency training. To provide a solid, common foundation for our scholars/trainees, we have developed Core
Activities required of all trainees in all training tracks. We are introducing several new program features to (i)
insure training milestones are achieved, (ii) facilitate preparation of F and K awards by trainees, (iii) better
integrate clinical and research training for our DMD/PhDs to enhance transition into an academic career, and
(iv) career development plans for teaching and laboratory management. UConn Health has a dynamic group of
faculty in various areas of research with highly successful collaborations among faculty throughout the Schools
of Dental Medicine and Medicine and The Jackson Laboratory for Genomic Medicine. The Biomedical Science
PhD program graduate faculty, active and new institutional research centers and clinical programs provide
contemporary laboratory, translational and patient oriented research opportunities that enable a diversified
training environment for the program tracks, allow flexibility for the individual needs of trainees, and ensure
successful progress through the tracks. The institution has vigorous trainee recruitment programs. Several are
directed towards under-represented minority candidates. We will continue to provide training that is tailored to
each candidate through symposia, seminars, courses, clinical research centers and collaborative research
activities which are integrated both within individual tracks and amongst all the tracks of the program.

Public health relevance
Project Narrative: The goal of this training program is to prepare individuals of outstanding potential for independent research careers in dental, oral and craniofacial research. Training of these individuals is critical to the health and quality of life of the American public.